Chronic Inflammation and Carcinogenesis

We determined that the immune suppressive cytokine IL-27, engineered into the food bacterium L.lactis, strongly inhibits intestinal inflammation in a mouse model of inflammatory bowel disease. A patent application was filed for this invention. Current efforts are to introduce the human version of IL-27 into a suitable vector for treating bowel inflammation. Together with collaborators, vectors under investigation are L.lactis, E.coli and yeast. If these efforts successfully generate a vector that produces human IL-27, we aim to develop a clinical trial in inflammatory bowel disease. Acute lymphoblastic leukemia studies in the laboratory will be discussed in a different project and includes development of a monoclonal antibody that is entering clinical trials.